Mental Health Research Network III

Summary: The Mental Health Research Network conducts practice-based mental health research in large healthcare systems serving over 25 million patients in 16 states. The network has the potential to dramatically improve the speed, efficiency, relevance and impact of mental health clinical and services research. A primary aim of this network is to have large-scale data infrastructure available for rapid analysis. With the onset of the COVID-19 pandemic, healthcare systems quickly changed from using mostly in-person clinic visits to telehealth visits that use phone or video to care for patients. However, we do not know how the change to telehealth affects people with mental health conditions. This supplemental application uses the infrastructure of the Mental Health Research Network to examine how changing from office visits to telehealth visits disrupts care of people with mental health conditions in three healthcare systems. We want to understand how this change to telehealth may affect people differently, including people of racial or ethnic minority groups, patients who speak a language other than English at home, children or teenagers, older adults, people with schizophrenia or bipolar disorder, people living in rural areas, or people living in areas with low income or education. We also want to understand how these changes affect the severity of someone’s anxiety or depression, whether they keep taking their mental health medications or continue going to therapy, whether they visit the emergency department or need to be hospitalized in the mental health unit, or whether they have increased risk to attempt suicide. Understanding the effects of transitioning to telehealth visits will help us understand who is, and is not, as able to access and engage in healthcare in future times of crisis - when going to the doctor’s office in person may not be safe - so that we can offer those patients more help and support. In addition, this research has broader implications regarding who benefits and who needs more support as the field of behavioral health care continues to rapidly transition to more regular use of telehealth services moving forward.

Public health relevance
Project Narrative: The Mental Health Research Network conducts practice-based mental health research in large healthcare systems serving over 25 million patients in 16 states, with a focus on having large-scale data infrastructure available for rapid analyses. This study takes advantage of that infrastructure to study how changing from in- person to phone- or video-visits during the COVID-19 crisis disrupts care of people with mental health conditions, including those in important and potentially disadvantaged subgroups. This work will help us understand who needs more support during crises as well as determine who benefits most from telehealth visits as the field of behavioral health care continues to transition to using more of these services.